Regulation of the neuroinflammatory response in autoimmune uveitis

Research Abstract: Autoimmune uveitis is a serious sight-threatening condition defined by an autoreactive
immune response against the retina and uveal tissues. In autoimmune uveitis, the retina and uveal tissues
become a target of autoreactive immune cells, which leads to irreversible neural damages and can progress to
significant visual impairment. Since the retina is a so-called “immune privileged” tissue protected by blood-
retinal barrier, how immune cells gain entry into the retina and what antigen presenting cell (APC) populations
are involved in local antigen presentation have been a long discussion. This proposal describes aims to
elucidate an innovative mechanism whereby retinal microglia mediate autoreactive immune cell entry into the
retina. Microglia are the resident immune cells of the central nervous system, including the retina, and function
in the homeostatic maintenance of the neuro-retinal microenvironment. The role and function of microglia in
disease progression is not well understood due to their multiple phenotypes and/or different stages of
activation that are associated with either harmful or beneficial effects in disease pathogenesis.
Our recent work demonstrated that microglial depletion inhibits development of EAU and that microglia are
essential to disease induction. Interestingly, retinal microglia are significantly activated in response to EAU
disease induction, quickly localizing to the retinal vasculature. However, our data indicated that microglia do
not function as APCs in disease initiation, but in fact function to facilitate infiltration of a variety of circulating
immune cells into the neuroretina. Our data highly suggested that microglia are key population that initiates
blood-retinal barrier breakdown and that the circulating APCs and T cells that enter the retina trigger the
subsequent vision altering auto-inflammatory response. However, the mechanisms by which this occurs
remains unknown.
In this proposal, we will elucidate the mechanism by which autoreactive immune cells gain entry into the retina
and how the subsequent autoimmune response develops during disease progression in a mouse model of
experimental autoimmune uveitis (EAU). We will begin by defining the initiating APC populations in EAU and
the contribution of microglial expression of MHC-II during EAU disease progression. Moreover, we will identify
the activation and kinetics of retinal microglia and infiltrating immune cells in EAU induction by using a single
cell RNA sequence profiling. Lastly, we will define the role of SIRPalpha/CD47, an immune axis that is highly
regulated in EAU and that functions in phagocytosis initiation and immune cell reactivity. Understanding the
mechanism by which microglia initiate autoimmune uveitis will likely open new avenues of therapy for this
disease as well as other blinding neovascular ophthalmic diseases.

Public health relevance
Research Narrative/Statement: Autoimmune ocular inflammation can lead to permanent blindness due to the irreversible damage caused by autoreactive inflammatory cells. Identifying factors involved in the inflammatory cell entry into the retina and subsequent antigen presentation during uveitis is of significant value. Our work has identified resident microglia in the retina as facilitators of immune cell entry in the initiation of autoimmune uveitis; this proposal aims to define key target cells and molecules that allow for autoreactive immune cells to target the neuroretina in this neuroinflammatory disease.